Molecular Genetics Core

Project Summary/Abstract - Molecular Genetics Core
To understand complex biologic systems relevant to human disease, modern biomedical research relies on the
development of model organisms that mimic human physiology and pathophysiology. Indeed, genetic models
of human disease are crucial for hypothesis driven research and hypothesis testing in vivo. Having the
capacity to generate modern molecular tools is critical to scientific progress. Hence, the primary objectives
of the MGC are to provide expertise, consultation, training, and services enabling the development and
use of state-of-the-art genetic tools in support of diabetes-focused research, its complications and
related endocrine and metabolic disorders.